Cancer Center Administration

Project Summary/Abstract: Administration
Norris Cotton Cancer Center (NCCC) Administration bridges the Geisel School of Medicine at Dartmouth
College (Geisel) and Dartmouth-Hitchcock Health system (D-H). We have retained fully NCCC Administrative
staff experienced in their individual roles and collaborative as a team. We have taken central responsibility for
a year-long process to assemble the current CCSG application, including reorganization of Programs and
addition of new Career Enhancement and Community Outreach and Engagement components. NCCC
Administration centrally has the lead role in preparation of annual non-competitive Type 5 progress reports, for
both the parent P30 award and nine recent CCSG supplements, in both the standard NIH RPPR reporting
system and any additional award-specified reports, including alignment of clinical trial reporting with CTRP-
generated Data Table 4. We have lead administrative responsibility for 13 faculty recruited by NCCC and
housed in the Rubin building, including our two most recent recruits, and are staffing five current active and
pending searches. We centrally manage a membership process that reaches across both parent institutions
and three Dartmouth Graduate Schools, and we facilitated Leadership review of current Member status and
Program alignment. Our communication activities include maintenance of NCCC mailing lists and websites,
along with Research Program monthly calendars. We have lead responsibility at Geisel for cancer-specific, as
well as generic, Shared Resources, assisting in three S10 major equipment acquisitions, embedding new
services in existing cores, and enhancing an order and charge-entry system now adopted campus-wide. We
have expanded from one to two annual pilot project solicitations and have renewed successfully our American
Cancer Society Institutional Research Grant, which also serves The Jackson Laboratories. We have
consolidated remote basic and population science Members into our central Rubin Building and brought on-line
new facilities in the contiguous Williamson Translational Research Building. In addition to managing both
Geisel and D-H annual operating budgets, we have implemented for Leadership oversight an annual
philanthropic budget and extended quarterly review of Shared Resources’ financial performance to the faculty
positions for which we have lead responsibility. We continue to manage funds at both Geisel and D-H, which
informed the vision of the new Director, and we have implemented an annual distribution of research funds to
clinician Principal Investigators and Clinical Oncology Groups. In addition to the CCSG, its supplements, and
the faculty for which NCCC has a lead administrative role, we support multi-investigator grants administration,
such as our NCTN LAPS award. The Administrative role in strategic planning was most evident in the
contribution of reference documents and the convening of Members to participate in the 2018 updating of the
NCCC 5-year plan. With the arrival of a new Director and completion of a new 5-year strategic plan, NCCC
Administration will contribute significantly to implementation and assessment of emerging new initiatives.